ASSOCIATION OF DIET AND NUTRITIONAL STATUS WITH BARRETT'S ESOPHAGUS

The purpose of this project is to study the relationships of usual diet and nutritional status with Barrett's esophagus in order to design nutrition intervention strategies.